"Evaluating the role of monocytes in the development of an effective HIV vaccine response"

Project Summary:
The global epidemic of HIV continues to pose a major world health threat with more than 1.5 million new
infections diagnosed in 2021. Although significant efforts have been underway for more than 30 years to
develop a vaccine to prevent HIV infection, to date, only one trial has shown any significant efficacy at infection
prevention. A recent study showed that monocyte gene enrichment correlated with the antibody dependent Fc
effector functions thought to be the reason for this vaccine’s efficacy. Monocytes are highly versatile cells that
regulate immune response through direct and indirect ways through secretion of cytokines. Monocytes are
recognized for their ability to contribute to vaccine efficacy across multiple vaccines, including malaria,
influenza and BCG. We hypothesize that monocyte subpopulations play a critical role in regulating
development HIV vaccine elicited antibody response through innate help and that, once characterized, can be
harnessed to improve vaccine efficacy. We will investigate this by two aims. Aim 1 will evaluate changes in
monocyte gene expression following infection, auto-immune disease and vaccination using publicly available
data and validate in healthy subjects an. Aim 2 will specifically identify monocyte sub-type specific signatures
associated with antibody response after HIV vaccination from four recent HVTN trials using CITE-seq and a
novel discrete-state mathematical algorithm with in vitro validation. Dr. Keefer and Dr. Thakar are the ideal
mentors for this project given their expertise in HIV vaccine research and systems biology. Through this
project, I will develop my computational and translational research and build a foundation from which I can
transition to independence as a physician scientist.

Public health relevance
Project Narrative: With an estimated 1.5 million people newly infected with HIV in 2021 alone, HIV remains a critical global health threat and prevention of acquisition through vaccine development remains a priority. This project aims to characterize the role of monocytes in the development of HIV vaccine response using a systems biology approach, for use in future vaccine development. The training plan will provide me with the knowledge and experience to transition to an independently funded physician scientist working in systems biology and HIV vaccine development.